Leveraging Stored Platelet Bioenergetics to Improve Hemostatic Function Upon Transfusion

PROJECT SUMMARY / ABSTRACT
The overarching aim of this proposal is to advance the field of personalized transfusion medicine by identifying
optimal supplementation and storage procedures to yield platelet products with maximum hemostatic capacity
to improve outcomes in actively bleeding patients. There has been renewed interest in using cold-stored platelets
(CS-PLT) for bleeding patients due to their increased hemostatic function as compared to conventional room
temperature-stored platelets (RT-PLT). We have identified that there is a metabolic signature associated with
CS-PLT hemostatic function under physiologically relevant flow conditions. This signature suggests that CS-PLT
use thiol redox switches, an underappreciated area of redox biology, to protect from oxidative stress during
storage. Yet these switches may also confer enhanced hemostatic activity. The mechanisms by which thiol redox
switches modulate platelet activation, adhesion, aggregation, and procoagulant capacity are not well defined. In
addition, this points to the opportunity to alter the redox potential of platelet storage solutions through metabolic
supplementation to create a platelet product with improved hemostatic function. Lastly, there is a paucity of data
concerning the in vivo hemostatic efficacy of long-term stored CS-PLT with or without metabolic
supplementation. Thus, our central hypothesis is that cold storage induces a redox environment that is
associated with increased hemostatic function, and that by adjusting the redox potential of RT-PLT to mimic that
incurred by cold storage will confer improved hemostatic capacity. To test this, we have proposed three aims: (i)
to identify the thiol redox status of CS-PLT compared to RT-PLT and identify those switches that are associated
with platelet hemostatic function; (ii) to determine whether metabolic supplementation of stored platelets to
increase the redox potential potentiates hemostatic function; (iii) and to demonstrate in vivo hemostatic activity
of alternatively stored platelet products in murine models. Our collaborative team and premier transfusion
medicine research environment are ideally suited to perform these studies, to include the use of microfluidic
models of hemostasis and thrombosis and murine models which assess platelet product safety and efficacy.
Moreover, this proposal addresses two significant unmet needs. First, the need to extend availability and/or shelf
life of products due to critically low supplies. This is addressed through our assessment of CS-PLT stored up to
21 days and identification of supplementation strategies to improve the metabolic “age” of stored platelets.
Second, the need to transfuse patients with products that will be effective in stopping bleeding. We will provide
much needed data on in vivo hemostatic efficacy of CS-PLT and determine if metabolic supplementation of
platelets can enhance hemostatic function. Findings generated by this proposal will provide detailed mechanistic
data on CS-PLT with the aim of both improving platelet inventory management and most importantly, outcomes
in actively bleeding patients via personalized transfusion medicine.

Public health relevance
PROJECT NARRATIVE The research program outlined in this proposal will (i) provide novel mechanistic data on how platelet storage conditions alter platelet redox biology, altering the hemostatic capacity of stored platelet products, (ii) identify optimal redox potential storage conditions to reduce oxidative damage and increase hemostatic potential of stored platelet products without the need for cold storage, and (iii) use clinically relevant in vivo models to provide much needed data on the hemostatic efficacy and immune consequences of alternatively stored human platelet products. These objectives are exactly in line with needs outlined at the recent State of the Science in Transfusion Medicine pertaining to mechanistic aspects of components and transfusion, and novel strategies which could improve quality using personalized transfusion medicine approaches. We have assembled a highly qualified and apt research team to execute this project, and subsequently provide evidence for the use of novel platelet products to improve outcomes in actively bleeding patients.